DISCOLATION OF PORCINE MITOCHONDRIAL MALATE DEHYPROGENASE (MMDH)

Discolation of porcine mitochoidrial malate dehyprogenase (mMDH) using pressure, and study of the effect of alternate ligand and the disoclation curves obtained by pressure changes.